Examining the electroencephalographic fingerprint of default mode network hyperconnectivity for scalable and personalized neurofeedback in schizophrenia

PROJECT ABSTRACT
Auditory hallucinations (AHs) are one of the core symptoms of schizophrenia (SZ) and constitute a significant
source of suffering and disability. One third of SZ patients experience pharmacology-resistant AHs, such that it
is imperative to develop alternative/complementary treatment strategies. Researchers are beginning to
appreciate how mental illnesses are associated with specific changes in the complex patterns of communication
between different brain regions thanks to new advances in Magnetic Resonance Imaging (MRI). In particular,
innovations in functional Magnetic Resonance Imaging (fMRI) data acquisition and computational analysis, make
it now possible to reliably map the functional neuroanatomy of brain networks in a personalized way, offering a
potential avenue for identifying unique and individualized neurotherapeutic targets. Moreover, it is now possible
to tailor a personal and noninvasive intervention to help patients normalize communication within and between
complex brain networks using real-time neurofeedback— whereby patients observe and learn to regulate
selected aspects of their own brain activity—. AHs are characterized by elevated intrinsic functional connectivity
within the default mode network (DMN) and between DMN and other large-scale networks like the frontoparietal
control network (FPCN) and auditory cortices (i.e., superior temporal gyrus (STG)). We recently developed an
innovative real-time fMRI circuit neurofeedback (rt-fMRI-NF) paradigm whereby people observe a visual display
of ongoing DMN activation levels and use mindfulness as a strategy to volitionally regulate this difference. Our
research has shown that rt-fMRI-NF reduces DMN hyperconnectivity and increases DMN-FPCN anticorrelations,
with a correlated reduction of AHs among adults diagnosed with SZ. Unfortunately, to target the major brain
networks that function abnormally in neuropsychiatric conditions, neurofeedback currently relies on fMRI
technology, which is an expensive procedure involving a complex setup and patient burden. Since frequency-
specific components of electroencephalography (EEG) signals recorded on the scalp can serve as correlates of
fMRI activity patterns, including DMN activity and connectivity. Here we propose to validate the EEG
correlates of DMN interactions implicated in AHs using concurrent EEG-fMRI and to develop an EEG
“fingerprint” of these fMRI network dynamics. Hence, we will expand our successful rt-fMRI-NF strategy with
the innovative addition of concurrent EEG measurements. We will apply the latest advances in personalized
fMRI functional network mapping to define the features of EEG signal to predict and optimize the EEG fingerprint
of fMRI activity using advances in machine learning for bio-signals that may lead to future personalized, network-
based EEG neurofeedback circuit therapy for AHs in SZ. This study will offer key technical innovations that could
lead to novel and scalable clinical applications. We will richly (>30 minutes) sample 40 patients with SZ and AHs
with simultaneous EEG-fMRI to develop a pioneering and personalized EEG fingerprint of DMN dynamics and
so enable a scalable form of accurate network-based neurofeedback training to patients.

Public health relevance
PROJECT NARRATIVE Auditory hallucinations (AH) are one of the five cardinal symptoms of schizophrenia and one of the most distressing, with approximately 75% of patients diagnosed with schizophrenia suffering from AH and almost a third of those experiencing AH being not responsive to gold-standard pharmacological and psychotherapeutic treatment. We have pioneered a new candidate, computational neuroscience-based approach that addresses this need, known as network-based real-time functional Magnetic Resonance Imaging Neurofeedback (rt-fMRI- NF) that is a well-tolerated and effective approach for reducing the severity and frequency of AH. Because, this technique currently requires fMRI to deliver neurofeedback, which unfortunately is an expensive procedure involving a complex setup and participant burden, we propose to develop novel, non-invasive, personalized and scalable treatments that will improve outcomes and reduce relapse rates among SZ patients with treatment resistant AHs.